SLEEP DEPRIVATION EFFECT ON CEREBRAL FUNCTIONING, LEARNING &MEMORY

Examine the neurophysiology of 36 hours of total sleep deprivation. Learning and working memory tasks are used as probes into the pattern of cerebral activation before and after sleep deprivation.